Identifying the requirements for T cell exit from peripheral tissues during an immune response

Project Summary
An effective immune response requires moving the right cells to the right place at the right time. T cells,
an important set of immune cells, migrate extensively to fight infection. At steady state, T cells circulate among
specialized organs called lymph nodes, which are found throughout the body. Pathogens and debris drain from
infected tissues to local lymph nodes, and T cells survey the lymph nodes for signs of infection. After activation
and proliferation in the lymph node, T cells go to the site of infection. There, they fight infection and may ultimately
die, stay and form long-lived “resident memory” cells, or leave into lymphatics and recirculate. It has been shown
that the chemokine receptor CCR7 brings T cells into the lymph node, while sphingosine 1-phosphate receptor
1 (S1PR1) allows them to leave. Recent studies have provided an increasingly good understanding of T cell
entry into infected tissues, but exit from these tissues is still very poorly understood. The cues that guide T cell
exit from inflamed tissues are important to elucidate, as they likely regulate the duration of inflammation and
what kind of immune memory is generated. The goals of my work are to identify requirements for T cell exit from
infected tissues, which will ultimately enable a better understanding of how T cell exit from tissues affects the
immune response. In my first aim, I will assess the types of cells exiting and the role of CCR7 and S1P receptors
in T cell exit from inflamed skin, and in my second aim I will assess the role of the S1P transporter SPNS2 in
generating the S1P gradients that guide T cell egress from skin. My results may provide insight into strategies
to limit chronic inflammation, as well as strategies to develop vaccines that generate protective resident memory
T cells.

Public health relevance
Project Narrative Although we have an increasingly good understanding of how T cells migrate through lymphoid organs and reach sites of inflammation, we still do not understand an important part of a lymphocyte’s journey: how T cells exit from sites of inflammation. Understanding this aspect of T cell trafficking will be important for the development of vaccines that generate protective resident memory T cells, and for elucidating mechanisms involved in chronic inflammation. We aim to determine the cell types, receptors and gradients that regulate exit of T cells from inflamed tissues.